Mechanisms of muscle afferent sensitization after ischemia

Abstract: While great deal is understood about mechanisms of sensory transduction from the skin, relatively
little is known about this process from the muscles. As peripheral injuries resulting from repetitive
ischemic/reperfusion (I/R) are a major health issue that affects millions of people in the United States, this gap
in knowledge precludes us from identifying specific therapies for muscle pain or altered cardiovascular
responses to exercise in the context of ischemia. Peripheral I/R occurs in blood disorders such as sickle cell
disease, and in cardiovascular disorders such as peripheral vascular disease. Males and females display
different features of myalgia and exercise pressor reflexes (EPRs) under conditions of reduced peripheral
perfusion. The major goal of this study is to determine the sex specific molecular mechanisms of muscle
afferent sensitization that may underlie the transition from acute to chronic ischemic myalgia. Pilot data in
murine models of repetitive I/R injury suggest that peripheral sensitization in males is regulated by increased
DRG gene expression that is modulated by glial cell line-derived neurotrophic factor (GDNF) family receptor 1
(GFR1) in muscle nociceptors. In females, afferent sensitization, pain-related behaviors and altered EPRs
after repeated I/R injury may be regulated by increased interleukin 1 receptor type 1 (IL1r1) dependent gene
expression. We hypothesize that the prolonged effects of successive I/R injuries are mediated by GDNF
related peripheral sensitization in males and IL1 induced sensitization in females. Aim 1 will determine if
myofiber produced GDNF and DRG upregulation of GFR1, regulate the observed changes in muscle afferent
response properties, pain-related behaviors and altered EPRs after dual I/R in males. We will use muscle fiber
specific GDNF ablation or our novel in vivo siRNA-mediated knockdown of genes in single peripheral nerves in
conjunction with our ex vivo muscle afferent recording preparations or assays of pain-like behaviors and EPRs.
Aim 2 will utilize a similar approach except we will determine if macrophage produced IL1 or DRG
upregulation of IL1r1, regulate the novel changes in female muscle afferents or behaviors after successive I/R.
Finally, Aim 3 will use ex vivo recording and pain-related behavioral analyses to determine if expression
differences in AU-rich element RNA-binding protein 1 (AUF1) or the ras family member, RAN, modulates the
sex specific effects of successive I/R injuries between females versus males. Each of these aims will be
complemented by analysis of DRG and muscle gene expression. The studies outlined here will also provide a
novel direction in muscle neurobiology research that will go well beyond the incremental expansion of current
reports. Results will enable us to identify unique sex dependent mechanisms associated with muscle afferent
sensitization that underlie acute to chronic ischemic myalgia development after I/R injury. This may lead to the
formulation of more appropriate treatments for musculoskeletal pain or altered EPRs associated with ischemia/
reperfusion that target the proper receptor(s), primary afferent subpopulation(s) or peripheral target tissues.

Public health relevance
NARRATIVE The results of the proposed experiments will significantly enhance our understanding of the molecular mechanisms underlying sensory neuron responses and hopefully provide novel information for use in the development of new avenues of research and therapies for musculoskeletal pain and/ or altered cardiovascular reflexes associated with repetitive ischemia/ reperfusion injury. The information obtained from these novel studies will allow us to better understand the functional implications of sensitization in specific subpopulations of muscle sensory neurons and the role they play in sex specific development of ischemic myalgia.